Human Intracerebral Hemorrhage: Impact of Hematoma Size, Hemolysis and Iron Overload on Edema and White Matter Survival by MRI

Project Abstract – There is currently no evidence for an established treatment paradigm for
intracerebral hemorrhage (ICH). The most recent clinical trials on hematoma evacuation and
iron chelator treatment have not shown a significant improvement in neurological function. No
objective surrogate markers of disease severity currently exist to guide prognosis. MRI is
inherently more informative about local tissue changes following hemorrhage in the brain tissue
than CT. We have recently completed our first translational MRI study (R21 - NS099684)
validating MRI based evaluation of iron overload in the brain tissue following ICH in 20 patients.
We have also demonstrated in another completed R21 (NS-104663) that proportional
erythrolysis within hematoma can be quantified reliably on MRI. Its influence on iron overload to
the surrounding tissue, perihematomal edema and white matter (WM) survival within the
hematoma can be robustly recorded in acute and subacute phases (7 – 10 days) and chronic
phase (up to 6 month). In addition, our preliminary data shows that the above markers have a
correlation with surviving WM within hematoma and the perihematomal region. The proposed
study aims to track natural history of ICH in terms of variations in above mentioned multiple MRI
markers, from acute (7-10 days) to the chronic phase (up to 6 months). It will particularly
address the importance of early erythrolysis on perihematomal iron overload and acute white
matter injury (day 7-10); the impact of hematomal and perihematomal iron overload on white
matter tract survival (days 7-10); and the effect of iron overload on white matter tract recovery
and brain atrophy after ICH (day 180). This study is important because this translational work
will establish MRI markers of iron mediated neurotoxicity and thus better inform future trials,
objectively evaluating newer treatment strategies including both image-guided mechanical
hematoma evacuation as well as pharmacological therapy for ICH.

Public health relevance
Project Narrative- Intracerebral hemorrhage (ICH) is a devastating disease in our society, which currently has no validated treatment paradigm leading to improved clinical function. This project will attempt to validate surrogate objective biomarkers on currently, commercially available MRI sequences, to better understand the natural history of ICH in terms of iron- mediated neurotoxicity from 7-10 days to 6 months. This project has immense translational significance as such surrogate markers are lacking and the results will better inform future trials examining novel treatment paradigms to prove their efficacy in ICH.